Molecular Mechanism of Mammalian DNA Excision Repair and the Circadian Clock

ABSTRACT
We work on molecular mechanisms of nucleotide excision repair and the mammalian
circadian clock. We have recently made both the technological and mechanistic progress
in both of these areas and obtained direct evidence of inter-connectedness of these two
fields. Our findings in both fields are directly applicable to human health. We will apply
these new advances for the following objectives:
(1) We have developed higher resolution versions of our original XR-seq method for
genome-wide single-nucleotide resolution mapping of repair of all DNA damage that is
processed by nucleotide excision repair, including damage induced by carcinogens and
chemotherapeutic drugs. In addition, we developed Damage-seq methods for similarly
genome-wide single nucleotide resolution mapping of DNA damage. We have used the
combination of the two methods to discover repair hotspots and coldspots that do not
overlap damage hotspots or coldspots and have gained novel information on genome 3D
and repair. We will continue characterizing these features to link repair to epigenomic
markers, 3D genome organization, chromatin states, and replication timing.
(2) We will define the molecular mechanism of the mammalian circadian clock.
Recently, we demonstrated that Cryptochrome (CRY), and not Period (PER), is the
repressor in the mammalian transcription-translation feedback loop (TTFL), and that PER
acts either as a repressor or an activator, depending on the particular gene, in a CRY-
dependent manner. We will carry out experiments to reconstitute this model in an in vitro
system with purified proteins.
(3) Circadian clock, cancer, and chemotherapy. For the first time, we have been able
to map both damage formation by cisplatin and its repair in mouse tissues including liver,
kidney, and lung, genome-wide and at single-nucleotide resolution. We made the exciting
discovery that for most genes the transcribed strand (TS) and non-transcribed strand
(NTS) are repaired at different times of the day. We plan to take advantage of this finding
to develop more efficient chronotherapy regimens, first for colorectal cancers, and in the
future for other types of cancers that are treated with cisplatin and oxaliplatin. The
proposed research is innovative because it is based on our discoveries in the fields of
DNA repair and circadian clock, and it is significant because of its relevance for cancer
prevention and treatment.

Public health relevance
PROJECT NARRATIVE The goal of our research is to understand the mechanism and genomics of excision repair, the molecular mechanism of the mammalian circadian clock, and the regulation of repair by the circadian clock to develop mechanism-based strategies for cancer prevention and treatment.